Targeting bile acid composition to treat metabolic diseases

PROJECT SUMMARY
In the US, 42.4% of the adults are classified as obese. Obesity associated metabolic diseases, including type 2
diabetes (T2D), nonalcoholic fatty liver disease (NAFLD) and its progressive stage nonalcoholic steatohepatitis
(NASH), severely impact human quality of life and mortality. Current anti-obese and diabetic drugs are often
associated with different side effects, and currently there are no Food and Drug Administration (FDA) approved
drugs for NAFLD/NASH. The long-term goal is to meet this critical unmet need for innovative novel
pharmacological therapies with improved safety profiles and durable treatment effects for obesity and its
complications. Bile acids (BAs) play important roles in regulating lipid, glucose, and energy metabolism.
CYP8B1, is exclusively expressed in the liver and it functions specifically to control the ratio of 12α-
hydroxylated (OH)/non-12α-OH BAs in the-BA pool. CYP8B1 deficiency leads to reduction 12α-OH)/non-12α-
OH BAs ratio, resulting in metabolically beneficial effects including weight loss, ameliorated fatty liver and
inflammation, with insulin sensitivity, in mice and humans. The central hypothesis is that CYP8B1-specific
inhibitors may provide a unique pharmacological approach to treat obesity and related metabolic diseases. The
rationale for the proposed research is that no CYP8B1-specific inhibitors exist and the lack of high-throughput
screening (HTS) methods hinders the identification of CYP8B1-specific inhibitors. The objective of this grant
application is to develop strategies for CYP8B1 inhibition by identifying potent CYP8B1-specific inhibitors to
pharmacologically alleviate metabolic disorders in mouse disease models. We have established a high-
throughput screening (HTS) platform to identify and optimize CYP8B1-specific inhibitors with potent in vivo
efficacy in metabolic disease models toward drug development. The HTS was implemented for a ~45,000-
compound library that led to the identification of potent, specific CYP8B1 inhibitors with biochemical and
functional validation. Most importantly, we found that a lead CYP8B1 inhibitor compound that displayed strong
efficacy in inhibiting CYP8B1 in vivo. The novel HTS-assay and the identified candidate CYP8B1-inhibitors will
be used to test two Specific Aims: 1) identification and characterization of CYP8B1-specific inhibitors; and 2)
Determination of CYP8B1-specific inhibitor therapeutic effects in metabolic disease models. The completion of
this grant proposal will help us generate first-in-class candidates for drug development. The results will
positively impact efforts to improve obesity, T2D and NAFLD/NASH clinical outcomes.

Public health relevance
PROJECT NARRATIVE Nearly 1 in 3 people are overweight and nearly 2 in 5 people have obesity; so, obesity is a national epidemic. The proposed research is highly relevant to public health because new effective therapies for obesity and obesity-related complications (e.g., NAFLD/NASH and type 2 diabetes) are needed. The tools and knowledge gained, and the mechanistic details to be discovered in this proposal, all fit the purview of NIDDK's mission to reduce the burden of obesity and obesity-related metabolic complications.